Il-27-mediated immunoregulation in HSV-1 induced stromal keratitis

Project Summary
Among ocular infections, recurrent herpes simplex virus-1 (HSV-1) infection causes immune cell infiltration
and opacity in the cornea and triggers a severe immuno-inflammatory condition called herpetic stromal
keratitis (HSK). HSK is a painful condition and one of the leading causes of infectious blindness in the United
States and worldwide. Current HSK treatments, such as anti-virals combined with corticosteroids, are partially
effective, and prolonged use causes severe local and systemic side effects. Further, the emergence of multi-
drug-resistant HSV-1 strains in HSK patients is a major clinical challenge. Therefore, there is an unmet clinical
need to develop safe and effective immunotherapies to treat HSK. The selective induction of a potent anti-
viral state with minimal activation of inflammatory immune responses embodies a powerful means to treat
patients with recurrent HSK. In this application, we propose one such approach targeting IL-27, an
immunoregulatory cytokine, to induce endogenous anti-viral and anti-inflammatory responses after corneal
HSV-1 infection to suppress HSK progression. Macrophages (Mϕs) play a central role in initiating and
resolving inflammation during HSK progression. Intracellular dsDNA from HSV-1 is recognized by cyclic-
GMP-AMP (cGAMP) synthase (cGAS) and activates the stimulator of interferon genes (STING) pathway to
promote anti-viral immunity. HSV-1 infected Mϕs promote glycolysis with compensatory downregulation of
the tricarboxylic acid (TCA) cycle. We observed that the TCA cycle in activated Mϕs is disrupted with
increased immune-responsive gene 1 (Irg1) expression, an enzyme that converts citrate to itaconate.
Itaconate is an immunoregulatory mitochondrial metabolite that can play both pro- and anti-viral roles. Our
preliminary data suggest that ocular HSV-1 infection promotes Irg1 expression in the cornea and Mϕs to
suppress anti-viral immunity through negative regulation of the cGAS-STING pathway. Apart from pathogens,
cytokines regulate metabolism in Mϕs to modulate their effector functions. We show that HSV-1 induces IL-
27 expression in the cornea, and mice lacking the IL-27 receptor are highly susceptible to ocular HSV-1
infection with increased viral titers and HSK severity. We show that IL-27 attenuates HSV-1-induced glycolytic
metabolism in Mϕs and suppresses Irg1 expression to stimulate IFN-β and limit inflammatory cytokine
production. Based on these observations, we hypothesize that HSV-1 reprograms Mϕs to promote the Irg1 to
evade cGAS-STING-mediated anti-HSV-1 responses (Aim 1) and IL-27 attenuates HSV-1-induced glycolytic
metabolism in Mϕs to suppress inflammation and promote anti-viral immunity through inhibition of Irg1 to
activate cGAS-STING pathway (Aim 2). The primary outcome of this study will be to uncover how HSV-1
regulates Mϕ metabolism to evade anti-viral responses during HSK progression. Our proposed IL-27-based
approach will complement the current anti-viral and immunosuppressive HSK therapies to increase their
efficacy, thus lowering the risk of side effects.

Public health relevance
Project Narrative The recurrent herpes simplex virus (HSV)-1 infection of the cornea causes a vision-impairing chronic inflammatory condition called herpetic stromal keratitis (HSK). This project aims to investigate the molecular mechanisms for HSV-1-mediated macrophage metabolic reprogramming and how immunoregulatory cytokine IL-27 promotes antiviral and anti-inflammatory responses during HSK pathogenesis. Since current HSK treatment approaches are partially effective and cause severe side effects, the information gained from these studies will identify novel targets for developing new therapies to treat recurrent HSK.